Defining intracellular mitochondrial heterogeneity establishment and maintenance

Project Summary
Mitochondria are the subcellular compartment responsible for a majority of cellular metabolic events including
oxidative phosphorylation, heme biosynthesis, and other metabolic fluxes. Given the common depictions of
mitochondrial physiology, it is striking that two recent studies have discovered subsets of mitochondria that are
specialized in their functions and composition (2,10). In accordance with these findings, we posit the innovative
hypothesis that intracellular mitochondrial heterogeneity exists in cells and is maintained through intracellular
organelle-communication. In this proposal, we will define intracellular mitochondrial heterogeneity and discover
the characteristics of specialized mitochondria. Using independent techniques: 1) CRISPR-mediated endo-
tagging of select mitochondrial protein; 2) Proximity labeling and affinity purification of mitochondria, isolated
mitochondrial populations will undergo comparative proteomics and metabolomics with Steven Gygi (see
attached letter). A potential mechanism to establish mitochondrial heterogeneity in cells is to have distinct
modes of intracellular communication. In this context, we propose that organelle proximity (ER, Golgi,
peroxisome, lysosome, endosome, and lipid droplets) is necessary for the establishment and maintenance of
specialized mitochondria by changing their individual proteomes and thus, mitochondrial function and
metabolism. Additionally, we aim to uncover the roles for intracellular mitochondrial heterogeneity in cellular
homeostasis. Overall, the insights gained from the proposed experiments will provide an innovative and
exciting perspective on mitochondrial biology and homeostasis.

Public health relevance
Project Narrative Mitochondria are organelles which play essential roles in cellular metabolism, biosynthesis, apoptosis, and innate immunity and their dysfunction is often associated with diseases like diabetes, cancer, and non- alcoholic fatty liver disease. While most depictions of mitochondrial biology assume all mitochondria within a given cell function equivalently, our proposal aims to fully uncover intracellular mitochondrial heterogeneity (specialized populations of mitochondria) and how this specialization is important for cell homeostasis. Understanding the mechanisms of how these specialized mitochondrial populations arise and how they are maintained will illuminate a new field of mitochondrial biology and cellular metabolism.